Administrative Core

PROJECT SUMMARY/ABSTRACT – UCSF LIVER CENTER
For the project summary/abstract please refer to the OVERALL/OVERVIEW section.

Public health relevance
PROJECT NARRATIVE – UCSF LIVER CENTER For the project narrative please refer to the OVERALL/OVERVIEW section.